Machine Learning Approaches for Behavioral Phenotyping of Humanized Knock-in Models of Alzheimer's Disease

PROJECT SUMMARY
Preclinical efforts to develop treatments for cognitive impairment in Alzheimer’s disease have been hindered by
two barriers: time-consuming behavioral assays that often lack sensitivity, and transgenic (TG) mouse models
with APP overexpression that do not accurately recapitulate human pathogenesis. To overcome the second
barrier, newly-developed humanized App knock-in (App-KI) mouse models express AD-related human genes at
physiological levels. App-KI mice have prominent brain pathology, but inconsistent, milder or absent behavioral
phenotypes in many traditional behavioral tests, including Morris Water maze (Saito et al., 2014). These
limitations of standard behavioral testing, including lack of sensitivity, low throughput, and reproducibility
represent key methodological barriers to proper development of therapeutics in newly developed App-KI mice.
Without a solution to this problem, it is likely that translational and preclinical research will struggle to develop
therapies in models of early pathogenesis or sporadic AD characterized by mild or subtle behavioral phenotype
and lacking overt clinical disease manifestation. To overcome the limits of behavioral testing, we propose to
implement machine-learning (ML) approaches that offer complete, unbiased, and robust behavioral
characterization of even subtle behavioral phenotypes. Specifically, we propose to upgrade and refine our novel
computer vision ML approach (Aim #1), to validate it in App-KI and TG AD mouse models (Aim #2), and to apply
it to mice receiving a newly-developed anti-Aβ antibody to validate our approach in a preclinical setting (Aim #3).
We recently published our first iteration of an ML package that developed the VAME neural network to identify
behavioral motifs. VAME will be further developed to provide rapid testing of large cohorts, unbiased identification
of disease-associated behavioral deficits, and reproducible phenotypes across experimental conditions and
laboratories. Our proposal thereby addresses key limitations of standard behavioral testing and mouse modeling,
vertically advances the methodology of behavioral neuroscience, launches innovative biotechnological
development, and opens new horizons for dementia-related research, including the adaptation of the approaches
to humans. Successful completion of the proposed studies will provide a new preclinical tool for diagnosis,
assessment, and disease monitoring in mouse models of AD. In conclusion, will establish a novel machine-
learning behavioral phenotyping platform with the power to non-invasively identify robust behavioral alterations
in App-KI models of AD, removing a key methodological barrier to the translational study of MCI, and increasing
the value of behavioral research broadly.
This award will critically support the PI to undertake immersive entrepreneurial training experiences at local
universities and at a startup company focused on developing novel therapeutics for neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Progress in Alzheimer’s disease (AD) research will benefit from new tools for detecting behavioral changes that occur in early disease stages, when therapies are likely to be most effective at halting or reversing disease progression. We propose to develop a new AI-based method for detecting subtle behavioral changes in late- onset AD mouse models that lack clear behavioral impairments when tested with traditional behavioral approaches. The proposed research will contribute a new urgently-needed tool for understanding and measuring behavioral changes in AD and will increase the usefulness of mouse models of late-onset AD for the development of new therapies aimed at improving behavioral and cognitive health in AD patients.